Outreach Recruitment and Education (ORE) Core

SUMMARY OF THE OUTREACH, RECRUITMENT, AND ENGAGEMENT CORE
The Outreach, Recruitment, and Engagement (ORE) Core of the Yale ARDC will continue to assist the Clinical
Core in their recruitment of a clinical population, which will be accomplished through communication with
health care professionals, service providers, and the general public. We will work with the Clinical and other
Cores to engage and retain participants. We will enhance our educational efforts with the general public
through our collaboration with the Connecticut Chapter of the Alzheimer’s Association, the Yale Geriatric
Workforce Enhancement Program, and other community-based organizations. We have developed a
mechanism for tracking individuals seeking information on Alzheimer’s disease from a variety of sources. We
will fully operationalize, implement, and evaluate this model to track interested individuals, engage study
participants, and adapt our outreach efforts to identify and meet the information needs of potential participants.
We will educate and recruit minority participants through our interaction with local Federally Qualified Health
Centers, and the Cultural Ambassador Program of the Yale Center for Clinical Investigation (YCCI), as well as
develop a new ADRC Community Advisory Board to identify community leaders who can help advocate for
research participation and facilitate bi-directional information flow with the community. In continuing our
educational efforts for health care providers, we will focus on expanding dementia education to primary care
clinicians in the Northeast Medical Group practice network, who care for over 190,000 patients throughout
Connecticut, as well as eastern New York and Rhode Island. We will work with the Geriatric Workgroup of the
Yale New Haven Health System, in which the Northeast Medical Group participates, in these efforts. We will
assist the leaders of this group to develop protocols for cognitive assessment, identify community resources,
and to encourage participation of patients in research studies for the diagnosis and treatment of Alzheimer’s
disease. Throughout all these efforts, we will utilize, expand, and optimize existing infrastructure whenever
possible to leverage ADRC resources and help to ensure the implementation and sustainability of our
programs.

Public health relevance
PROJECT NARRATIVE: Per the program announcement, the Cumulative Project Narrative has been included in the Overall Component, Other Project Information section.